Maintenance of an SPF Macaque Breeding Colony for AIDS Research

PROJECT SUMMARY/ABSTRACT – OVERALL
The Tulane National Primate Research Center (TNPRC) has one of the largest rhesus monkey breeding colonies
in the United States. The objective of this application is to request funds for continued support and maintenance
of the U42-supported specific pathogen-free (SPF) Indian-origin rhesus monkey breeding colony at the TNPRC.
We will moderately increase production over the next few years due to recent developments in funding and
animal demand. The specific aims address the components specified in the Notice of Funding Opportunity
(NOFO) and are divided into the overall program description, husbandry core, viral testing core, and MHC genetic
typing core. Program income and TNPRC funds will be used to fund components of the program not covered by
grant funds, including per diem for any colony animals in excess of the animals supported by this application,
additional testing required for those animals, infrastructure repairs and improvements, veterinary clinical and
pathology support, behavioral management support, and portions of the genetic testing.
Specific Aims:
Overall. To maintain the existing SPF colony and distribute available animals to the NIH-funded HIV/AIDS
research community.
Husbandry and Management Core. To provide husbandry and veterinary care for the SPF breeding colony.
This includes a robust program for clinical veterinary medical care and behavioral management. The colony has
reached a mature, self-sustaining status with ideal demographics for production that allow making up to 150
animals available for research assignment each year. Program income generated by the sale of animals will be
returned to an account for use in supporting the aims of the grant.
Viral Testing Core. To assure the SPF status of the colony through continued viral testing of existing breeding
colony animals and all offspring. Continue to expand characterization of the colony beyond the required 4 viruses
to include agents such as measles virus, SARS-CoV-2, Trypanosoma cruzi, and other emerging infectious
diseases that threaten nonhuman primates.
MHC Genetic Typing Core. To continue genetic analysis and MHC typing of the SPF colony and provide
expanded genetic characterization through enhanced techniques.

Public health relevance
PROJECT NARRATIVE – OVERALL The Tulane National Primate Research Center (TNPRC) has one of the largest specific pathogen-free (SPF) rhesus monkey breeding colonies in the United States, a resource that has provided animals for NIH-funded research projects for several decades and is a critical component of the Center’s successful HIV/AIDS research program. Over half of all research projects at TNPRC are initiated by outside investigators, making this resource essential to the success of many NIH-funded researchers across the country. Experienced leadership and significant infrastructure investment, combined with proven techniques in breeding colony management, ensure continued responsible stewardship of this nationally recognized resource for HIV/AIDS-related research.